Optimizing methadone treatment strategies for opioid use disorder in the era of fentanyl

PROJECT SUMMARY
Treatment with medications for opioid use disorder is a critical intervention with proven effectiveness for
improving morbidity, mortality and quality of life, yet only a minority of patients with an opioid use disorder are
engaged in treatment and ongoing use of fentanyl during treatment is common. Current methadone treatment
protocols were developed and validated based on studies performed in populations with heroin use, with a focus
on diversion prevention and minimizing overdose risk. A deadlier drug supply dominated by fentanyl has altered
this risk-benefit assessment and evidence-based updates are urgently needed. Challenges of methadone
initiation and maintenance in patients with fentanyl use are well-documented. Inadequate control of withdrawal
and cravings at standard methadone doses due to higher levels of opioid tolerance and physical dependence in
individuals with a history of fentanyl use may contribute to ongoing use of non-prescribed opioids and increased
overdose risk. Failure to reach a therapeutic dose expediently can result in a perceived lack of efficacy, adding
additional barriers to treatment engagement and retention. In response, some addiction medicine specialists
have suggested that accelerated initiation trajectories combined with higher maintenance doses are needed, but
there are no standardized protocols for patients using fentanyl and wide variability in methadone dispensing
practice. Limited data suggest that higher doses and expanded ‘take-homes’ among people with a history of
fentanyl use do not contribute to excess deaths from methadone, but these studies lack longitudinal patient-level
effectiveness and safety data to draw firm conclusions to support practice change. This study seeks to evaluate
the effectiveness and safety of different methadone treatment strategies, including dosing and expanded take-
home flexibilities associated with the COVID-19 pandemic, on treatment retention and non-fatal/fatal overdose
in a retrospective cohort of patients (n~10,000) initiating medication treatment for an opioid use disorder with
methadone in the fentanyl era. The data-rich environment in Rhode Island and established relationships with
non-profit opioid treatment programs and state agencies will be leveraged to assemble a single, comprehensive,
longitudinal novel dataset that will include both electronic health record data (detailed patient characteristics and
methadone dispensing data) and state administrative data (with emergency medical services and emergency
department visits for non-fatal opioid overdose, medical examiner records for fatal overdoses, corrections, and
controlled substance prescribing information) Results of this study will help resolve long-standing questions
about the optimal methadone dosing strategies and directly inform opioid use disorder clinical treatment best
practices for patients who use fentanyl, thereby reducing the risk of overdose and improving treatment retention.

Public health relevance
PROJECT NARRATIVE Methadone is a cornerstone of treatment for opioid use disorders (OUD), but a worsening overdose crisis and widespread fentanyl use demand re-evaluation of dosing strategies and take-home treatment. This study will create a unique linked database combining electronic health record and state administrative databases to enable an unprecedented evaluation into methadone treatment strategies and outcomes during a time of expanded and changing methadone flexibilities in a fentanyl-endemic area. Results of this study will help to resolve long-standing questions around optimal methadone dosing strategies and will directly inform OUD clinical treatment best practices for patients who use fentanyl, thereby reducing the risk of overdose and improving treatment retention.